Longitudinal Mapping of Human Brain Development in the First Years of Life

Longitudinal Mapping of Human Brain Development in the First Years of Life
Abstract
This proposal requests continued funding support for research at the University of North Carolina at Chapel Hill
to develop computational tools for quantifying longitudinal structural changes in the human brain. The previous
project period has been extremely successful in advancing robust tools for longitudinal brain analysis of the aging
brain. In this renewal, we seek to further advance robust computational tools for comprehensive longitudinal
characterization of changes in the early developing brain. This is in line with our long-term goal of creating
computational tools for longitudinal charting of brain evolution across the entire human lifespan. The tools to be
developed in this project will allow uniﬁed and concurrent analysis of longitudinal volumetric data and cortical
surfaces, facilitating the mapping of dynamic and spatially heterogeneous structural changes during a critical
period of brain development.
The tools developed in this project will be tailored to studying the human brain in the ﬁrst few years of life, which
undergoes dynamic development in both structure and function. We will utilize the MRI data made available via
the Baby Connectome Project (BCP), involving 500 pediatric subjects scanned from birth to ﬁve years of age. The
outcome of BCP will inform neuroscientists what normal healthy growth looks like and facilitate discovery of the
earliest manifestations of brain disorders. To fully beneﬁt from this unique dataset, dedicated computational tools
are needed for accurate processing and analysis of baby MR images, which typically exhibit dynamic heteroge-
neous changes across time. However, most computational tools developed to date have been mostly focused on
adult subjects and are unreliable when applied to baby MRI. We propose to address this gap with three aims:
In Aim 1, we will develop computational tools to allow multifaceted analysis of MRI data, including volumes and
white-matter/pial surfaces, to be carried out in common spaces for a more holistic understanding of the early
developing brain. Our tools will explicitly consider the rapid changes in MR image appearances that are typical in
the ﬁrst year of life. Unlike conventional methods that are designed for either image volumes or cortical surfaces,
resulting in inconsistencies and loss of sensitivity to subtle changes, our tools will allow joint volume-surface
analysis in consistent longitudinal spaces. Improving registration accuracy by drawing information from both
entities is critical for detecting subtle changes in the developing brain, which is signiﬁcantly smaller with a thinner
cerebral cortex.
In Aim 2, we will generate longitudinal, multimodal, and whole-brain parcellation maps for the early developing
brain. Subdivision of the brain into coherent regions is an essential step in the macroscopic mapping of spa-
tially heterogeneous changes and in the examination of spatial and topological organization. Our approach will
allow the characterization of the evolution of parcellation across time and at the same time maintain temporal
consistency and inter-subject correspondences of the parcels.
In Aim 3, we will develop techniques that will allow prediction of missing MRI data to increase the usability of
incomplete data for improving statistical power. Missing data is a common and inevitable problem in longitudinal
studies due to subject dropouts or failed scans, especially in studies involving infants. To address this problem,
we will develop deep learning techniques for longitudinal prediction of missing imaging data.
Successful completion of this project will empower the neuroscience community with computational tools for more
precise charting of the normative early development of the human brain using MRI. As part of this project, we will
deliver the ﬁrst set of temporally-dense surface-volumetric atlases that will capture key developmental traits
and are therefore critical for quantiﬁcation of possible deviation from normal brain development.

Public health relevance
Project Narrative Unlike the vast majority of computational tools that are developed for adult brain MRI with good image con- trast, this project will empower neuroscience researchers with robust tools needed to quantify temporal structural changes in the early developing brain, including tools for (i) Uniﬁed longitudinal analysis of volumetric and surface data of infant MRI; (ii) Multimodal parcellation with longitudinal and intersubject consistency; (iii) Deep learning prediction of missing data. The tools developed will be disseminated in the form of a software package complete with documentation and tutorials. As part of this project, we will deliver the ﬁrst set of temporally-dense surface- volumetric atlases that will capture key developmental traits, critical for quantiﬁcation of possible deviation from normal brain development.